Aerosolized microbots as a platform for targeted lung therapy

Project Summary: Lung cancer is the leading cause of cancer death among men and women,
making up almost 25% of all cancer deaths. For cancers beyond stage 1 some form of
chemotherapy is usually given often causing side effects including cytotoxicity, cardiotoxicity,
and nephrotoxicity. Avoiding systemic methods by directly delivering chemotherapeutics to the
lungs can avoid some of these; however, toxicities remain because chemotherapeutic drugs are
not selectively delivered to cancerous cells. We propose here the use of aerosolized and then in
situ assembled microbots capable of carrying drug for transport and delivery of
chemotherapeutics to specific locations within the lung. Our scientific premise is that individual
µbot components of optimal aerodynamic size range can be inhaled into the lungs and
assembled in place for subsequent travel down airways to target lung cancer for delivery of
chemotherapeutic agents. As both µwheel assembly and driving forces are provided by an
external magnetic field, once the procedure is finished, microbots disassemble into small beads
removable by the body's natural mechanism for removal of dust and other foreign particles in
the mucus lining. Our aims include: Aim 1. Identify magnetic field conditions for aerosolized µbot
swarm targeted delivery within in vitro models. Focused on targeted transport within increasingly
complex 2D and 3D in vitro lung models, here magnetic-field based targeting approaches will be
tested, first within 2D bifurcating microfluidic models and then 3D printed models based on
available lung mapping. Aim 2. Determine aerosolized µbot design for drug delivery within in
vitro models. Focused on drug transport, we will investigate µbot design and manipulation for
the delivery of chemotherapeutic drugs. Aim 3. Quantify the functional benefit of targeted µbot
delivery in vivo. Focused on in vivo transport and efficacy, we will use a mouse model for testing
of both µbot targeting and drug delivery.

Public health relevance
Project Narrative: The proposed research is relevant to public health because targeted methods for the treatment of lung cancer are lacking. In this research aerosolizable particles manipulated by external magnetic fields will form microbots capable of transporting chemotherapeutic drugs to cancerous tumors within the lungs. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to the application of innovative strategies for improving health.